Social, Assistive Mobile Manipulator (SAMM) to enhance functional independence in persons with tetraplegia secondary to severe cervical spinal cord injury

Project Summary/Abstract
Spinal cord injuries (SCIs) can have a devastating impact on individuals and their families, as well as on
society as a whole. According to the National Spinal Cord Injury Statistical Center, in the US there are
approximately 17,500 new cases of SCI each year and an estimated 300,000 people living with SCI. The lifetime
cost of care for a person with SCI can be in the millions of dollars, and the physical and emotional toll on
individuals and their families can be immense. People with SCI-induced tetraplegia (SCI-IT), who make up more
than half of the SCI population, often require round-the-clock care and assistance with basic activities such as
bathing, dressing, and eating. This places a tremendous burden on caregivers, who may struggle to balance
their caregiving responsibilities with work and other obligations. In addition to the physical challenges, people
with SCI may experience depression, anxiety, and social isolation, which can further impact their quality of life.
Dramatic improvements in survival with no known cure result in an unmet need to facilitate independent living
for people with SCI and improve their psychosocial well-being while reducing the burden on at-home caregivers.
One promising approach to reducing caregiver burden and facilitating patient independence is to apply
advances in autonomous and social robotics to physical task assistance. The use of mobile robots with arms
capable of manipulating objects, or mobile manipulators (e.g., Stretch-3), in dynamic environments (e.g., a home)
to perform tasks is a scientific frontier ripe for application. However, these new robotic capabilities must be paired
with the latest social robot interaction capabilities, which have been used to promote psychosocial health in
people’s homes but are unable to perform physical tasks on behalf of end users. To explore the profound benefit
these technologies can have on persons with SCI and their caregivers, Charles River Analytics, in partnership
with Spaulding Rehabilitation Hospital, Harvard Medical School, will prototype and demonstrate the feasibility of
a Social, Assistive Mobile Manipulator (SAMM) software suite to enhance functional independence and
psychosocial well-being in people with SCI. Phase I will culminate in a demonstration of SAMM, an assistive
technology that integrates a commercially available robotic system with a novel software framework that includes
manipulation, navigation, perception, and natural language to provide task-based actions with social
engagement.

Public health relevance
Project Narrative People with spinal cord injuries (SCIs) and SCI-induced tetraplegia (SCI-IT) are dependent on caregivers for activities and instrumental activities of daily living, severely reducing their autonomy and mental health while placing a high burden on their caregivers. Social, Assistive Mobile Manipulator (SAMM) is a software suite that provides an assistive mobile manipulator with planning, navigation, perception, and manipulation algorithms along with a novel social interface that promotes independence and psychosocial well-being among people with SCI by performing tasks on their behalf with an engaging and friendly personality. An assistive mobile manipulator capable of meaningful work in a dynamic environment, such as the home, with a social interface to improve mental health would be a boon for populations needing domestic physical assistance, such as the hundreds of thousands of people with SCI in the US.